Understanding Response Shift in Acute Respiratory Distress Syndrome (ARDS) survivors

Project Summary / Abstract
Acute respiratory distress syndrome (ARDS) is a severe lung injury usually requiring mechanical ventilation in
an intensive care unit (ICU). While the number of ICU patients requiring mechanical ventilation is steadily
increasing, in-hospital mortality is declining, creating a growing population of ARDS survivors. Such survivorship
comes at a high “cost,” with ARDS patients frequently experiencing new or worsening physical, cognitive, and/or
mental health impairments that last for years after ARDS. NHLBI and professional societies identify improving
quality of life for ARDS survivors as a key research priority. Some ARDS survivors may adapt to new
impairments over time and report improving quality of life not explained by improvements in objective measures
of their physical, cognitive, and mental health. This adaptation phenomenon is known as “response shift.” We
hypothesize that ARDS survivors demonstrate widely varying degrees of response shift, and that patients'
baseline characteristics prior to ARDS have important associations with the magnitude of response shift after
ICU discharge. We also investigate how psychosocial factors, including trait anxiety, social support, resilience,
and survivor expectations for functional recovery, impact quality of life during recovery as a first step toward
designing and evaluating new interventions for ARDS survivors.
This proposal will exploit a unique, pre-existing cohort of very well-characterized ARDS survivors from
the NHLBI ARDS Network Long Term Outcome Study (ALTOS) containing hundreds of data elements per
patient. Using modern data science methods, I will empirically evaluate the association between baseline patient
characteristics and response shift between 6 and 12 months after ARDS [Aim 1], and identify the changes in
specific aspects of physical, cognitive, and mental health, from among ~165 candidate measures, that best
predict changes in quality of life [Aim 2]. To investigate how psychosocial factors impact quality of life, I will
conduct a new, prospective, ICU cohort study of ARDS survivors to collect data for these novel analyses [Aim
3]. The results from these three Aims will generate new knowledge regarding empirically-derived, testable
hypotheses about important determinants of quality of life, and provide essential data for designing future studies
of interventions aimed at improving the quality of life of ARDS survivors.
This career development award provides training in data science, patient outcomes-oriented clinical
research, and machine learning statistical techniques for the applicant who is a PhD-trained epidemiologist
without these skills. Immediate, short-term, and long-term career goals include: (1) publishing results of the
proposed research, (2) successfully competing for R-level funding to explore whether addressing psychosocial
issues, including setting appropriate patient expectations for recovery, is a potentially modifiable, low-cost
intervention to improve ARDS survivor's quality of life, and (3) becoming an NHLBI-funded independent research
scientist who conducts innovative and methodologically rigorous data science research on ARDS outcomes.

Public health relevance
Project Narrative A large and growing number of acute respiratory distress syndrome (ARDS) survivors frequently experience new and long-lasting physical, cognitive, and mental health impairments. ARDS survivors may exhibit a phenomenon known as “response shift” in which survivors adapt to new impairments and report improving quality of life not explained by improvements in objective measures of their physical, cognitive, and mental health. Using a cohort of very well-characterized ARDS survivors, this project will evaluate the association between individual-level response shift and patient characteristics, identify the changes in specific aspects of physical, cognitive, and mental health that best predict changes in quality of life between 6 and 12 months after ICU discharge, and evaluate the association between psychosocial factors including patient expectations for functional recovery and quality of life during recovery from ARDS.